Genetics of chronotype and impact on metabolic disease

Project Summary/ Abstract
Dys-regulation of the body's internal circadian time-keeping mechanism is an established risk factor for metabolic
disease. Chronotype, or preference in timing of behaviors during the 24 hour day, reflects underlying circadian
rhythms and can be assessed by questionnaires and actigraphy in large populations. Our long-term goal is to
use human genetics to elucidate pathways that link sleep and circadian regulation to cardio-metabolic disease
with the aim to develop therapeutic interventions that leverage insights from human genetic approaches. The
overall objective of this application is to identify the variants, genes, and mechanisms responsible for chronotype
and understand how alterations in biological timing of these genes interfaces with metabolic physiology and
disease. In the first funding period, we identified 351 novel loci for chronotype, sleep and activity timing traits by
leading and contributing to GWAS of circadian and sleep traits in the UK Biobank. We identified genetic variants
implicating circadian rhythms and also insulin regulation pathways, providing opportunities to understand the
biological causes and consequences of circadian rhythm disturbances and their relationship with human
metabolic physiology. We hypothesize that more complete identification of causal common, rare and structural
variants by whole genome sequencing, clustering of variants by multi-trait associations and tissue- and cell-type
specific annotations, as well as functional genomic analyses of pleiotropic signals between chronotype and
metabolic disease using computational and experimental approaches will illuminate circadian rhythm pathways
and the mechanisms linking them to type 2 diabetes. In the next phase of this research, we leverage whole-
genome sequencing, proteomics and metabolomics in large biobanks including UK Biobank and TOPMed
cohorts as well as high-throughput experimental perturbation studies to pursue the following specific aims: 1) to
characterize common, rare and structural genetic variants underlying chronotype using genome sequencing; 2)
to dissect mechanistic pathways by which variants and genes influence chronotype using analyses of existing
multi-omic resources as well as experimental assays, and 3) to define molecular links between chronotype, daily
molecular and behavioral rhythms and T2D by analyses of pleiotropy, colocalization and gene x behavior
associations. This work will reveal mechanistic links of timing of the internal circadian rhythm to type 2 diabetes,
opening potential new avenues of treatment for circadian rhythm disorders and type 2 diabetes.

Public health relevance
Narrative Morningness and eveningness are common traits, but little is known about how these changes reflecting internal circadian rhythm are caused at the molecular level, and how genetic variation in chronotype relates to metabolic disease. We will use human genetics and functional assays to understand the role of known and newly identified genes that contribute to differences in chronotype among individuals, and genetic relationship to diabetes. This work should inform knowledge of causes of morningness and eveningness, their link to metabolism and is relevant for leading to better prevention, diagnosis and therapies for circadian disorders and type 2 diabetes.